An Open Resource for Autism iPSCs and Their Derivatives

DESCRIPTION (provided by applicant): The autism spectrum disorders (ASDs) comprise a set of neurodevelopmental disorders that are, at best, still poorly understood and, yet, they are the fastest growing developmental disorder in the United States. Analysis of the post-mortem brain has provided some of the most valuable data for advancing our understanding of ASD pathophysiology. In addition, neural stem cells (NSCs) can be harvested from the post- mortem ASD brain, providing a critical tool for the study of ASDs, as detailed examination of the proliferation and differentiation of NSCs derived from ASD brains, compared with those derived from normal brains, is likely to yield important data regarding the etiology of the disease and provide new avenues for therapeutic approaches. The procurement of post-mortem ASD brains, however, has proven to be difficult. Thus, the generation of sufficient numbers of ASD NSC lines has been slow. Recent advances in stem cell research now allow for this difficulty to be overcome. It is now possible to de-differentiate or re-program human fibroblasts to an induced pluripotent stem cell (iPSC) state; that is, a line of stem cells that can differentiate into virtually any tissue cell type, such as brain, can be created from a fibroblast cell. This raises the potential of applying this technology to fibroblasts derived from ASD patients to allow study of resulting NSCs. Since fibroblasts are readily procured, sufficient statistical power for a whole host of studies can be achieved. We will apply the reprogramming technique to both fibroblasts derived from well- characterized patients with autism as well as those derived from normal individuals. Using the recently described gene candidates for reprogramming cells, we will transduce fibroblasts using published methods and characterize their conversion to iPSCs. We will use existing cell lines or cells lines recruited with our collaborators, procured under our stem cell-specific consent, for both the re-programming methodology and the compare and contrast evaluation of resulting cell lines. Specific methodology evaluation will be accomplished using fibroblasts and NSCs, already in our repository, that were derived from the same patients. The implication for the study of the ASDs simply cannot be overstated. Efficient generation of autism NSC lines will allow for studies that have never before been possible. These include (1) studies examining the detailed pathophysiology of the autism neuron, (2) studies of sufficient statistical power that can compare and contrast the effects of autism on neuronal differentiation, and (3) studies of the influence of environmental factors on these processes. Importantly, all data generated will be made available. The lines themselves will also be made available to the scientific community through our existing stem cell repository. This will leverage our efforts for maximal benefit to patients and families affected by autism. PUBLIC HEALTH RELEVANCE: The overall purpose of this project is to overcome a critical barrier in the field of autism research; namely, accessibility to statistically relevant numbers of patient-derived neural tissues. Our novel strategy, which is based on our considerable human neural stem cell (NSC), human embryonic stem cell (ESC), and biorepository experience, is to obtain fibroblasts from specific autism and control patients, derive induced pluripotent stem cells (iPSCs) from the fibroblasts, differentiate NSCs from the iPSCs, characterize and contrast and compare these cells using gene microarray and bioinformatics techniques, and provide the cells to specific autism researchers.

Public health relevance
NARRATIVE The overall purpose of this project is to overcome a critical barrier in the field of autism research; namely, accessibility to statistically relevant numbers of patient-derived neural tissues. Our novel strategy, which is based on our considerable human neural stem cell (NSC), human embryonic stem cell (ESC), and biorepository experience, is to obtain fibroblasts from specific autism and control patients, derive induced pluripotent stem cells (iPSCs) from the fibroblasts, differentiate NSCs from the iPSCs, characterize and contrast and compare these cells using gene microarray and bioinformatics techniques, and provide the cells to specific autism researchers. Dr. James Thomson of the University of Wisconsin will act as consultant for the iPSC portion of this effort. Dr. Jeanne Loring of The Scripps Research Institute will act as consultant for the bioinformatics portion of this effort. This strategy will put the maximum number of patient-derived neural tissues (i.e. neural cell lines) in the maximum number of researchers' hands. Specific Aim #1: Generation and Characterization of Autism and Control iPSC Lines Patient recruitment: Expertise and infrastructure for patient recruitment and consent already exists with the National Human Neural Stem Cell Resource (NHNSCR), which the PI founded and directs. Using the expertise of an existing autism clinical team, specific autism and control patients will be identified and recruited to give consent for donation of either existing fibroblasts or of a piece of biopsy skin from which fibroblasts may be derived. The consortium PI, Dr. Randi Hagerman, of the UCDavis MIND Institute will work with the PI on this goal. In addition, Dr. Jane Pickett of the Autism Tissue Program (ATP) of Autism Speaks, and Dr. Clara Lajonchere of the Autism Genetic Resource Exchange (AGRE) of Autism Speaks will act as consultants. iPSC derivation: iPSCs will be derived from the fibroblasts, using existing methodologies, by transducing them with lentiviral vectors encoding for the transcription factor genes OCT4, NANOG, LIN28, and SOX2. This work will be done in collaboration with Dr. James Thomson of the University of Wisconsin. Considerable expertise for PSC culture and characterization already exists in the PI's lab. In addition, the PI has recently received a supplement from the NIH to add iPSC derivation to his human ESC training course. iPSC characterization: All iPSCs will be characterized using immunocytochemistry and gene microarray (Dr. Jeanne Loring, collaborator) and will be karyotyped and analyzed for identity and stability by SNP genotyping. CNV analysis will also be done (Dr. Heather Mefford, collaborator) iPSCs will be expanded and banked at early and later passages. Specific Aim #2: NSC Differentiation and Characterization Neural Differentiation: iPSCs, after they have been sufficiently expanded, characterized, and banked, will be induced to differentiate down the neural lineage into neural stem cells using established procedures. Considerable expertise for human NSC culture and characterization already exists in the PI's lab. NSC Characterization: NSCs will be characterized using immunocytochemistry and gene microarray and will be karyotyped and analyzed for identity and stability by SNP genotyping. NSCs will be expanded and banked at early and later passages. Specific Aim #3: Cell Distribution Researcher recruitment: Researchers likely to make use of the iPSC/NSCs will be found using the NIH's Crisp database and the researchers database of the Autism Tissue Program and AGRE of Autism Speaks. California researchers meeting these criteria have already been identified and will be the first to benefit from this autism iPSC/NSC repository. Considerable expertise for stem cell distribution already exists in the PI's lab. Training: Researchers wishing to use the iPSCs or the NSCs, but lacking sufficient expertise, will be brought to our laboratories and either thoroughly trained or be allowed to carry out their preliminary studies. Considerable expertise for stem cell training already exists in our laboratory.